Mapping the Cerebellar Origins of Medulloblastoma Subgroups

PROJECT SUMMARY
Childhood cancers are the consequence of failed normal development. Medulloblastoma (MB), a malignant
embryonal tumor of the cerebellum, exemplifies a highly aggressive pediatric cancer driven by aberrant activation
of neurodevelopmental pathways and disruption of neuronal differentiation programs. Genomics has effectively
divided MB into biologically and clinically distinct consensus molecular subgroups, including WNT, SHH, Group
3, and Group 4. Mouse tumor modeling studies have substantiated the cellular origins of WNT- and SHH-MB. In
contrast, the developmental basis of Group 3/4-MB remains poorly understood, hampering context-relevant
mechanistic studies, generation of accurate disease models, and the advancement of molecularly targeted
therapies urgently needed to improve patient outcomes. Recent single-cell genomics studies lead by PI Northcott
and others have provided initial clues into the putative origins of Group 4-MB, the largest and least characterized
MB subgroup, implicating multiple glutamatergic lineages born out of the upper rhombic lip germinal zone.
However, these studies failed to confidently identify cerebellar correlates of Group 3-MB, the most clinically
challenging MB subgroup. Decoding the interplay between cellular lineages of the developing cerebellum and
Group 3/4-MB pathogenesis represents a fundamental challenge in the field and will be the primary objective of
this research program. We hypothesize that Group 3/4-MB tumors arise from discrete lineage trajectories during
early cerebellar development. Solving the developmental origins of Group 3/4-MB will provide essential
knowledge required to (i) investigate context-specific mechanisms of tumorigenesis; (ii) inform preclinical
modeling strategies; (iii) identify previously hidden oncogenic drivers; and (iv) illuminate novel therapeutic
opportunities. This hypothesis will be tested in three conceptually and technically innovative Specific Aims that
integrate a multidisciplinary and multispecies experimental approach. In Aim #1, we will leverage an
unprecedented single-cell transcriptional atlas of murine cerebellar development and elegant lineage enrichment
strategies to enable cross-species inference of MB subgroup origins and execute context-relevant experimental
perturbation of MB driver genes. In Aim #2, we will deliver the first comprehensive investigation of MB cellular
origins through the lens of human fetal cerebellar development. These analyses will enlighten species-specific
differences in cerebellar development linked to tumorigenesis and foster the discovery of tumor-specific
signatures driving malignancy. In Aim #3, we will use focused CRISPR targeting, acute protein degradation, and
next-generation synthetic gene regulators to define developmentally linked transcriptional dependencies in high-
risk MB. These studies will credential conserved master transcription factors as attractive leads for future
therapeutic consideration. Successful execution of this research program will fill an essential knowledge gap
associated with the known biological and clinical heterogeneity of Group 3/4-MB and provide a novel direction
for the pursuit of more specific, less toxic treatment options for affected children.

Public health relevance
PROJECT NARRATIVE Medulloblastoma (MB) is a highly aggressive embryonal tumor of the cerebellum for which safer and more effective therapies are urgently needed. The developmental basis of molecularly and clinically distinct MB subgroups remains ill-defined, hampering the generation of accurate disease models required for mechanistic understanding and preclinical evaluation. This proposal will discover developmental origins of poorly characterized MB subgroups, and experimentally credential transcriptional dependencies defining subgroup identity as a novel therapeutic vulnerability in high-risk patients.